Dissecting Tumor-Immune Interactions in HIV-HPV Co-Infection-Associated Oropharyngeal Cancer using Single Cell Sequencing and Novel Mouse Models

Project Summary/Abstract
Oropharyngeal squamous cell carcinoma (OPSCC) has emerged as a significant global health concern, with
increasing incidence attributed to human papillomavirus (HPV) infection. Additionally, individuals living with
HIV/AIDS (PLWH) face a higher risk of developing OPSCC. Understanding the synergistic relationships between
HIV and oral HPV infection in OPSCC development is critical for advancing prevention, diagnosis, and treatment
strategies. CD8+ T cells play a pivotal role in antiviral immunity and tumor surveillance. However, the impact of
HIV infection on CD8+ T cells remains largely unexplored. Recently, we have identified an HPV integration
hotspot in the PD-L1 gene, contributing to CD8+ T cell exhaustion. In addition, our single-cell analysis revealed
a unique subset of exhausted CD8+ T cells associated with HIV-HPV co-infection in the OPSCC
microenvironment. We hypothesize that HIV co-infection induces elevated dysfunction/exhaustion of tumor-
infiltrating lymphocytes (TILs), particularly CD8+ T cells, in the OPSCC microenvironment. As a multi-PI
application, combining our expertise in single-cell analysis and functional analysis of HIV mouse models and
CD8+ T cells, we will investigate the impact of HIV infection on the immune cell landscape of HPV-positive
OPSCC (Aim 1). Additionally, we will characterize the phenotype and specificity of tumor-infiltrating CD8+ T cell
receptors (TCRs) and correlate them with cellular exhaustion status in the context HIV-HPV co-infection (Aim 2).
Furthermore, we will establish a novel mouse model that faithfully recapitulates HIV-HPV co-infection in OPSCC
to explore dynamic interactions between viral infection, tumor progression, and CD8+ T cells (Aim 3). Additionally,
we will investigate the impact of combined antiretroviral therapy (ART) and immune checkpoint blockade on
restoring tumor-reactive CD8+ T cell function and preventing HPV-induced neoplastic growth. This research
aims to enhance our understanding of HIV-HPV co-infection's influence on immune responses and immune
evasion in oropharyngeal cancer. Findings may inform novel therapeutic strategies to enhance immune
responses and improve clinical outcomes for OPSCC patients living with HIV and have broader implications for
other HPV-associated malignancies.

Public health relevance
Project Narrative Our study explores the impact of HIV and oral HPV infection on the immune response in oropharyngeal cancer. Specifically, we will examine how CD8+ T cells, essential for combating viruses and tumors, are influenced by HIV-HPV co-infection. The results aim to improve prevention, diagnosis, and treatment approaches for HPV- positive oropharyngeal cancer patients, especially those living with HIV, with broader implications for other HPV- related malignancies.